Collaborative computational biology research

Since joining NICHD in January 2022, I have started collaborating with Dr. Tonja Nansel from the Social and Behavioral Sciences Branch and Dr. Katie Grantz from the Epidemiology Branch to analyze microbiome data from the Pregnancy and Eating Attributes Study (PEAS) and metabolomics data from the NICHD Fetal Growth Study. I have also started collaborating with Dr. Elodie Gheldin from National Institute of Allergy and Infectious Diseases
(NIAID) and Dr. Leo Segal from New York University (NYU) to analyze microbiome, metabolomics from a COVID cohort.